Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: SUMMARY
The DRP is an essential component of the Brain SPORE, providing yearly support to 3-4 projects that have translational potential. Funding is flexible, supporting projects for a period of two years or less. It is expected that DRP investigators will develop their pilots sufficiently to either replace main projects that have reached conclusion or are not progressing. If there is no such need, DRP project investigators will be encouraged to secure independent funding, such as through the R01 mechanism. The DRP will be maintained for the entire project period; SPORE funds will be matched by Institutional support. In collaboration with the Northwestern’s Brain Tumor Institute at the Lurie Cancer Center, there will be a highly structured process for solicitation, review and evaluation of pilot projects.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: NARRATIVE The Developmental Research Program (DRP) of the Northwestern Brain Tumor SPORE provides yearly funding for projects that have promising translational potential. DRP project investigators will be encouraged to secure independent funding in brain cancer research, or their project may replace main projects that are not progressing or that have achieved translational endpoint.